PSORALEN INDUCED MELATONIN SECRETION

Will attempt to confirm reports that psoralens, at the dose routinely used photochemotherapeutically but without subsequent exposure to ultraviolet light, provoke increases in circulating levels of endogenous melatonin.